Inborn Errors In Immunity

ABSTRACT
Support is requested for a Keystone Symposia conference entitled Inborn Error of Immunity, organized by Drs.
Dusan Bogunovic, Isabelle Meyts and Steven Holland. The conference will be a virtual event from October 17-
19, 2022.
Inborn errors of immunity (IEIs) are a growing group of over 400 genetic disorders in which individuals present
with immune deficiency, immune dysregulation, or both. IEIs combine genomics, next generation
transcriptomics and epigenomics, biochemistry, as well as innate and adaptive immunology research, with
diverse aspects of clinical medicine ranging from clinical genetics and immunology to metabolism, neurology
and dermatology, to name only a few. Bridging these canonically isolated fields into a coherent collaborative
scientific enterprise is both essential and a challenge. The historical landscape in IEI has been dominated by
concepts of immune deficiency and ensuing susceptibility to infections, but recent discoveries have uncovered
genetic errors predisposing to autoinflammatory diseases, and perhaps most surprising those that predispose
individuals to both infection and inflammation. The conference is focused on showcasing the genetic errors of
the immune system affecting both the innate and adaptive branches. Moreover, it will greatly evolve this
emerging field by identifying, studying and crosspollinating studies which discuss both pro- and anti-
inflammatory and infectious immune effectors. Finally, this program will also address knowledge gaps in
pathways that regulate these immune effectors and suggest rational approaches to target these in patients.

Public health relevance
PROJECT NARRATIVE Inborn errors of immunity (IEIs) are a growing group of genetic disorders in which individuals present with immune deficiency, immune dysregulation, or both. Clinicians and researchers are tasked with understanding, diagnosing and treating patients with these inherited immune disorders. This conference will address knowledge gaps in pathways that regulate these immune effectors and discuss novel approaches to target these in patients in order to improve health.